Regulatory Mechanisms Controlling P. gingivalis Surface Structures

Porphyromonas gingivalis (Pg) is an endogenous pathogen, strongly implicated in the etiology of adult
periodontal disease. This research will increase our understanding of the molecular mechanisms that control
synthesis of Pg’s capsule and membrane lipids. Our overarching model is that the biofilm state acts as a
reservoir of bacteria, while capsule synthesis is linked to a transition to virulence and disruption of
homeostasis. We have shown that DNABII family members in Pg (HU PG0121 and HU PG1258) are
involved in controlling production of capsule. In general, DNABII proteins are known to be critical for
regulation of cell metabolism, the response to environmental perturbations, and in controlling the transition to
and from a quiescent state. Central to our studies is an antisense RNA (asSuGR, for antisense Surface
Glycan Regulator) encoded at the 5’-end of the capsule locus (PG0104-PG0121) within a novel 77bp
inverted repeat (77bpIR) element. Deletion or over- expression of asSuGR alters the synthesis of both K-
antigen capsule and LPS, and expression is, in part, controlled by the two-component response regulator
PG0720. In addition, we have determined that synthesis of a certain subset of sphingolipids is required for
the presentation of K-antigen capsule on the cell surface, and this finding aligns with our discovery of a
matching asSuGR target sequence in a sphingolipid-synthesis locus (PG1780-PG1788). Our working model
is that genes involved in K- antigen capsule and SL-synthesis are coordinately regulated by asSuGR. In
these studies, we will determine how DNABII proteins along with other regulatory proteins and asSuGR
modulate the synthesis of capsule, LPS, and sphingolipids and we will elucidate the ligand/signal that
activates the two-component system (PG0719-PG0720). Our overall goal is to identify regulatory pathways
that control the switch from a persistent, surface-attached state to a virulent state capable of disrupting
microbe-host homeostasis. The research proposed in this application is significant because understanding
the control of surface property changes is a vital link to understanding the switch this bacterium makes to a
virulent pathogen. As an outcome of these studies, we will have characterized mechanisms that control the
synthesis of key virulence determinants. This information will lead to a better understanding of the regulatory
networks that either direct P. gingivalis to become a virulent pathogen or to continue to lie low and persist.
Our results will potentially lead to the development of new therapeutic strategies for modulating biofilm
growth and persistence of this oral pathogen.

Public health relevance
Periodontal diseases are common chronic inflammatory disease, afflicting up to 50% of the adult population in the United States and associated with systemic diseases, such as diabetes and cardiovascular disease. The proliferation of anaerobic bacteria below the gumline is central to disease progression, with Porphyromonas gingivalis being implicated as one of the primary endogenous pathogens. We are studying how this bacterium controls the production of its surface polysaccharides and membrane lipids, which are key determinants of its virulence.